Administrative Core

PROJECT SUMMARY (Administrative Core)
The Administrative Core of the CReATe Consortium is responsible for coordinating and supporting all activities
of the CReATe Consortium, to enable this Rare Diseases Clinical Research Consortium (RDCRC) to achieve
its scientific, educational and stakeholder engagement goals, and to function effectively as part of the Rare
Diseases Clinical Research Network (RDCRN). The Administrative Core is responsible for providing project
management as well as data management & biostatistical support, oversight of the CReATe biorepository, and
outreach & advocacy activities. As such, the Administrative Core serves as a hub for the Consortium, with the
principal goals of enabling efficient protocol development and execution; facilitating communication both within
the Consortium and with patient advocacy groups and other key stakeholders; and partnering with the RDCRN
Data Management and Coordinating Center (DMCC) to foster Network activities and to promote rare disease
research more generally. The specific aims for the Administrative Core, as part of this renewal application, are
to: (1) implement efficient and effective processes that support the scientific rigor and productivity of the
CReATe Consortium’s research activities; (2) promote collaborative partnership with patient advocacy groups
and other strategic partners, including patients, family members and caregivers; and (3) develop and
disseminate resources that are valuable to the broader scientific community engaged in ALS and related
disorders research. These include the CReATe Data Repository, the CReATe Biorepository, CReATe genomic
data (available through the St. Jude Cloud) and the ALS Toolkit, a module developed within the Epic electronic
health record, that facilitates the systematic collection of structured clinical/phenotypic data from patients
receiving care in a multi-disciplinary ALS clinic.